Developing a Comparative Single-Cell Spatial Transciptomic Atlas of Brain Aging in Non-Human and Humans

Project Summary
Aging leads to an increased risk of neurodegenerative diseases such as Alzheimer's and Parkinson's that
present significant public health challenges worldwide. Despite extensive research, the molecular mechanisms
driving brain aging remain poorly understood, especially at the single-cell level within critical regions like the
prefrontal cortex and hippocampus. Due to their close genetic and physiological similarities to humans, including
comparable brain structure and aging processes, non-human primates (NHPs) like rhesus macaques are
invaluable models for studying the intricacies of brain aging.
This project aims to develop the first lifespan-matched, comparative single-cell spatial transcriptomic atlas of the
prefrontal cortex and hippocampus in humans and rhesus macaques. Using the cutting-edge CosMx Spatial
Molecular Imager (SMI), we will generate high-resolution, single-cell gene expression profiles across different
life stages—young, adult, and aged—in both species. Our central hypothesis is that aging induces specific,
identifiable spatial and cell-type-specific gene expression alterations conserved between humans and rhesus
macaques, contributing to neurodegeneration.
Under the guidance of expert mentors, the candidate will receive comprehensive training in NHP aging models,
advanced spatial transcriptomics using the CosMx SMI platform, human neuropathology, data interpretation, and
cross-species comparative analysis using integrative bioinformatics, leading to a deep understanding of the
molecular mechanisms underlying brain aging.
This project will fill a critical gap in our understanding of brain aging by providing the first lifespan-matched,
comparative single-cell spatial transcriptomic atlases of key brain regions in humans and rhesus macaques. We
anticipate that our findings will (i) advance our knowledge of age-associated molecular changes and (ii) identify
conserved pathways contributing to neurodegeneration. Ultimately, this research has the potential to inform the
development of therapeutic targets to mitigate neurodegenerative diseases, significantly impacting aging
research and public health.

Public health relevance
Project Narrative As people age, they often experience cognitive decline and an increased risk for neurodegenerative diseases like Alzheimer's, which significantly impact quality of life. This research will create detailed, single-cell maps of brain regions critical for memory and cognition—the prefrontal cortex and hippocampus—by comparing tissues from humans and closely related non-human primates across different life stages. By identifying specific molecular and cellular changes associated with aging, this study seeks to uncover pathways that could offer promising new strategies for treating, or even preventing, age-related cognitive decline and neurodegenerative diseases, ultimately improving brain health and quality of life for the aging population.